Deciphering the Glycan Code in Human Alzheimer's Disease Brain

Abstract:
Alzheimer’s disease (AD) is a devastating diagnosis and there is a critical need to understand the fundamental
molecular pathogenesis of AD to design effective therapies. In addition to the well-known AD pathologies,
perturbed glucose metabolism is also a clinical feature of AD. Glycogen and N-linked glycans are two critically
important but understudied facets of glucose metabolism. Both glycogen and N-linked glycans are complex
carbohydrates that play vital roles in brain physiology such as cognition, memory formation, and life span.
Despite the importance of these pathways in normal brain function, whether complex carbohydrate metabolism
are perturbed during AD disease progression remains a critical knowledge gap in neurobiology. In exciting
preliminary data, we discovered profound glycogen accumulation and protein hyperglycosylation in the
prefrontal cortex of both mouse models of AD and human AD specimens. Further, we found a positive
correlation between increased glycogen and Braak staging in an analysis of a 97-patient cohort. Finally, oral
glucosamine supplement, a precursor to UDP-N-acetylglucosamine biosynthesis, building block of N-linked
glycans further exacerbated hyperglycosylation and led to poorer cognitive performance in the 5xFAD mouse
model of AD. Based on these preliminary data, we hypothesize that aberrant complex carbohydrate
metabolism are pathogenic processes during AD disease progression. The major objective of this study is to
systematically resolve cellular and extracellular origins of perturbed complex carbohydrate metabolism using
state-of-the-art single cell technologies. We will achieve this through synergistic integration of multi-parameter
single-cell mass spectrometry imaging methodologies. First, we will define complex carbohydrates with clinical
course and disease progression in patient samples (Aim 1). Then, we will interrogate cellular and extra-cellular
architecture in normal and AD patient samples (Aim 2). Finally, we will apply multimodal integration to track
cellular and extracellular origins of complex carbohydrate perturbation in AD (Aim 3). This study will provide
critical new information regarding ideal cell-, region- and temporally-specific opportunities for therapeutic
modulation of AD. Collectively, we believe the resultant findings from this proposal will be highly salient for
multiple related fields of Alzheimer’s disease and other neurodegenerative disorders.

Public health relevance
Project Narrative Glycosylation is an abundant and complex co-translational modification of proteins that impacts protein folding, maturation, stability, subcellular localization, and enzymatic activity. While critical roles of N-linked glycosylation are beginning to emerge in the brain, its involvement in Alzheimer's disease (AD) remains largely unknown. We provided preliminary data in support of N-linked glycan alterations as a driver of AD disease pathology, the goal of this proposal is to define the cellular and extracellular events underlying altered N-link glycan metabolism in AD.